The 14th International BMP Conference: Multi-functionality of the BMP Signaling Pathway in Development, Health, and Disease

Summary
The bone morphogenetic proteins (BMP) and their downstream signaling pathways are critical regulators of
key developmental and physiological processes and when altered, cause severe pathologies including
developmental defects, organ failures and cancer. The International BMP Conference - now in its 14th
occurrence - is a unique, unmatched and fundamental forum in which to assess the most recent research
advances from national and international leaders and identify and discuss the most pressing questions moving
forward. As its predecessors, it will offer the unique opportunity to bring together not only established
physician-scientists and scientists but also young investigators, students and new-comers to the field who will
spend several full days together to hear, assess and discuss the most advanced research, to consider the
BMP field in all its facets and to envision its future. The conference will thus integrate basic and essential
aspects of BMP signaling and function with the work of developmental biologists, cancer biologists,
musculoskeletal, cardiovascular, and physician-scientists, structural biologists and computational biologists, all
aimed at understanding the molecular, cellular and biochemical underpinnings of BMP family signal
transduction and mechanisms of action in diverse physiological and pathological contexts. Attendees use a
broad spectrum of approaches from human patient to model organisms and in vitro experimental methods,
along with large-scale proteomic, transcriptomic and other genome-wide methods to unravel, define and
understand the roles, regulation, fine-tuning and pathology of BMP signaling in these challenging and different
contexts. The Specific Aims are: Aim 1: To assess and disseminate the latest, unpublished results in the BMP
pathway signaling field, providing an exchange of knowledge and advice through talks and informal
interactions at poster sessions. Aim 2: To foster collaborations, intellectual exchange, and interdisciplinary
approaches by bringing together diverse investigators including clinicians, biochemists and cellular and
structural biologists, and all those in between in order to promote integrative approaches to elucidate BMP
family signaling and its components. Aim 3: Building the next cohort of BMP scientists by providing supportive
and interactive forums for graduate students, postdoctoral fellows, research associates, and junior faculty to
meet and interact with senior scientists, providing networking opportunities and training and career
development venues. In addition to invited experts, speakers will be chosen from submitted abstracts to
highlight late breaking high-impact research, emphasizing work by early-stage investigators. The requested
support for the 14th International BMP Conference would be a significant contribution toward fulfilling the
conference's goals to stimulate creativity and collaborations in basic, translational and clinical research into a
key cell and developmental signaling pathway, as well as to provide early career stage investigators with
strong support to promote and develop their talent.

Public health relevance
Narrative The bone morphogenetic proteins (BMP) and their downstream signaling pathways are critical regulators of key developmental and physiological processes and when altered, cause severe pathologies including developmental defects, organ failures and cancer. The International BMP Conference - now in its 14th occurrence - is a unique, unmatched and fundamental forum in which to assess the most recent research advances in the field and identify and discuss the most pressing questions moving forward. As its predecessors, it will offer the unique opportunity to bring together established physician-scientists and scientists with young investigators, students and new comers to the field who will spend several full days together to hear, assess and discuss the most advanced research, consider the BMP field in all its facets and envision its future.